CRCNS: Investigating how neural dynamics transition along the time-frequency axis across scales

While extensive evidence has shown the importance of whole-person approaches to physical and
mental health, existing therapeutic interventions for neurological and mental disorders remain largely
single-scale and segregated. The brain, in contrast, is a vastly multiscale and interconnected complex
system, and neural dynamics transform dramatically across spatiotemporal scales, internal states, and
external contexts. In particular, numerous bodies of neuroscience research have discovered methods for
describing brain (dys)function in the time domain, whereas many parallel, largely disconnected efforts have
discovered ways to characterize neural dynamics in the frequency domain. The goal of this project is to
integrate the complementary dimensions of time and frequency into a unifying theory through the
development of causal discovery methods across broad spatiotemporal scales, internal states, and external
contexts. Based on extensive preliminary data, our central hypothesis (CH) is that causal mechanisms in
complex networked systems such as the brain can be discovered more accurately and robustly in the
frequency domain under (both of) two conditions: sufficient spatiotemporal averaging and sufficient
stationarity of underlying dynamics. We test our CH through three Specific Aims, each of which combines
formal mathematical analysis, causal algorithm design, large-scale numerical simulations, and in vivo
electrophysiology and calcium imaging. Aim 1 tests the working hypothesis (WH) that stationary
macroscopic causal mechanisms can be learned more robustly and accurately in the frequency domain.
Aim 2 then tests the WH that mesoscopic causal mechanisms can best be understood using a novel form
of integrated time-frequency analysis that avoids using conventional, Fourier-based decompositions, while
Aim 3 tests the WH that macroscopic causal network mechanisms can be more accurately discovered
using time-domain methods during the transient period following extrinsic events. The proposed research is
thus highly synergistic with the NCCIH Strategic Plan, especially “Objective 1: Advance fundamental
science and methods development”. Through the development of innovative causal discovery methods, the
proposed research provides the computational theory needed to identify optimal intervention targets across
scales and conditions. This project pioneers a transition from conventional, single-scale to a causal,
systems understanding of neural information processing. Consequently, it will lay a rigorous foundation for
much-needed holistic and multi-scale intervention design for neurological and mental disorders.
RELEVANCE (See instructions):
This project is relevant to public health because it develops an integrated framework for determining
(1) where (at what nodes) and (2) how (in what “language”) to intervene for brain-related disorders. We
achieve (1) by developing methods for identifying causal network mechanisms across broad spatiotemporal
scales. We achieve (2) by developing a complex-systems theory to determine which analysis domain—time
or frequency—is most appropriate for answering which sets of questions, at what scale, and why.